Integration of the thalamic and cortical inputs in the auditory striatum

Animals facing a decision routinely use sensory including auditory information from the outside world to
guide optimal behavior. For example, we listen for instructions from the GPS when trying to take the best
route to a destination. The dorsal striatum is a critical brain region in this sensory-guided decision-making
process. The long-term goal of my laboratory is to understand the circuitry and mechanisms through which
the dorsal striatum transforms auditory stimuli into appropriate actions. Anatomical studies have shown that
individual neurons in the dorsal striatum receive convergent inputs from both the thalamus and the cortex.
Previous studies in associative striatum (rostral dorsal striatum) suggest that these two input pathways play
distinct roles in behaviors. Our studies in sensory striatum (caudal dorsal striatum) indicate that projections
from both the auditory thalamus and the auditory cortex are required for decision-making in rodents
performing an auditory frequency-discrimination task. The primary objective of this proposal is to determine
how the auditory striatum integrates these thalamic and cortical inputs, and how this integration
contributes to auditory frequency-discrimination decision-making and learning. The studies proposed
address the fundamental hypothesis that both thalamic and cortical inputs contribute to auditory decision-
making by differentially modulating striatal sound representations, and by shaping striatal synaptic plasticity
during task learning.
In Aim 1, we will determine how striatal sound representation is regulated by the thalamic and cortical
inputs. We will use in vivo tetrode recording on awake mice to examine the responses of striatal neurons to
pure tones while thalamic or cortical inputs are selectively silenced during stimulus presentation. In Aim 2, we
will examine how striatal neurons integrate the thalamic and cortical inputs using whole-cell patch recording
in brain slice combined with opto-genetic and pharmacological applications. In Aim 3, we will examine the
development of thalamostriatal plasticity during task learning and test how thalamic input influences the
learning-induced corticostriatal plasticity, using in vivo tetrode recording on behaving mice.
The proposed experiments will determine how thalamostriatal and corticostriatal pathways regulate
auditory striatal activity and plasticity, the physiological mechanisms underlying their functions in auditory
decision-making. We focus on the auditory striatum in this study, but the findings may be generalized to the
whole sensory striatum. These results will also contribute to the understanding of brain disorders like
Parkinson’s and Huntington’s disease that involve differential changes of activity and plasticity at
thalamostriatal and corticostriatal synapses.

Public health relevance
Auditory information guides our daily behavior, including decision-making, the flexible transformation of information from the outside world into action. The striatum has emerged as a key player in reward-driven decisions, which are important both in everyday life and in many brain disorders, including Huntington’s and Parkinson’s disease. This proposal focuses on the circuitry and mechanisms by which the auditory striatum integrate inputs from the auditory thalamus and cortex in an auditory frequency-discrimination task. We expect that these experiments will improve understanding of auditory decision-making and learning. They may also provide insights that will facilitate the development of treatments for the deficits in sensory-guided decision-making that occur in many neurological disorders.